Protein interactions that control calcium oxalate stone formation

Kidney stones remain an enigmatic disease despite decades of work by many investigators with no real
advancement in calcium oxalate (CaOx) stone treatment for more than 20 years, beyond the focus on lowering
urinary supersaturation with respect to CaOx crystals. While the recurrence rate can be reduced, the disease
cannot be cured with current therapies. With prevalence of approximately 10% in most developed countries and
increasing in recent years, research that could define the mechanisms underlying stone formation is increasingly
relevant. Organic materials (mainly proteins) appear to coat all crystal surfaces in CaOx stones, and the presence
of proteins appears to be critical to stone formation. These protein crystal aggregates form spontaneously (self-
assemble) to form dense solid objects with substantial mechanical strength. No single protein is critical to this
process. We have focused for many years on mixtures of strong polyanions (PA) with strong polycations (PC),
which self aggregate at low concentrations and induce CaOx crystal aggregation when mixed in roughly equal
proportions. Direct measurements of protein compositions in stone matrix have demonstrated enrichment of PA
and PC in stones, but also demonstrated a major fraction of many weakly ionic proteins that exhibit preferential
adsorption to stone matrix compared to urine. Unfortunately, the sheer number of proteins comprising stone
matrix obscures the nature of their role in stone formation, yet these broadly constituted mixtures clearly yield
hard, dense aggregates when mixed with CaOx crystals. The protein mixtures found in other kidney stone types
are similar in most proteins, and other mineralized tissues, like human bone and mollusk shells, contain similarly
broad protein mixtures with many common features. Furthermore, studies of PA/PC mixtures in polymer science
show that these systems phase separate (aggregate), but don't achieve the dense solid concentrations of
polymers observed in stones. We hypothesize that CaOx stone formation is dependent on a complex
mixture of proteins, including strongly anionic, strongly cationic, and weakly charged proteins that
interact with CaOx crystals to produce the dense protein-crystal aggregates (composites) with high
mechanical strength that are kidney stones. We will use the established protein compositions of CaOx stone
matrix as a starting point for making controlled mixtures of well characterized polymers and proteins and studying
their interactions with CaOx crystals to understand the self-assembly of stone like composites, as well as their
mechanical properties. Our study team is ideally suited to this task, including a clinician with polymer physical
chemistry training and kidney stone experience and an expert in chemical engineering and polyelectrolyte phase
behavior. The proposed work includes 3 Specific Aims. 1: Test a range of protein/polymer compositions for
their ability to alter CaOx crystallization processes (nucleation, growth, and aggregation). 2: Measure the
mechanical strength of CaOx crystal aggregates spontaneously formed with these mixtures. 3: Prepare
macroscopic composites (simulated stones) for mechanical testing to bridge understanding to clinical disease.

Public health relevance
Calcium oxalate kidney stones are a common, recurrent condition (affecting about 10% of the US population) with increasingly prevalence, but preventative treatments are only incompletely effective. Stones are aggregates of calcium oxalate crystals held together by a complex mixture of urinary proteins, though the matrix phase and its role in mechanical strength is poorly understood. The proposed experiments will characterize the protein-protein interactions and their influence on protein-crystal interactions involved in stone formation, so that we can better understand matrix contributions and design better treatments.